DDT-IST-000016-LOI-2 A Human Liver-Chip for Prediction of Drug-Induced Liver Injury proposed for context of use claim for the prediction of DILI within preclinical drug development program

RFA-FD-24-030
Application Identifier: 1690535
Project Summary/Abstract:
Drug-induced liver injury (DILI) is a leading cause of post-market drug
withdrawal, clinical trial failures, patient fatality, and liver transplantations. It is,
therefore, a serious cause for concern and thus accurate and timely prediction
of DILI is required to assure patient safety during clinical trial. But DILI is a
complex process and human-relevant models, such as organ-chips, are being
considered as tools for DILI prediction. Organ-Chips recreate the complex and
dynamic state in which living cells function in vivo which in turn drives
appropriate cell morphology, function, differentiation, and gene expression.
The Emulate quad-culture Liver-Chip, which consists of primary human
hepatocytes, Kupffer cells, stellate cells, and liver sinusoidal endothelial cells
(LSECs) demonstrated its ability to predict DILI across 18 small molecule drugs
with a sensitivity of 87% and a specificity of 100%. Furthermore, it was able to
differentiate between toxic and non-toxic drugs within the same class. Although
DILI risk needs to be evaluated preclinically for all candidate drugs, it bares
particular importance when the new candidate is in the same class as an
earlier drug that displayed DILI in the clinic. In such cases, there is a higher a
priori risk that the new candidate drug will also display DILI, and so it may
require a higher level of scrutiny by regulators. Accordingly, regulators may
seek data that facilitates the comparison of DILI risk between the new
candidate and prior drug, for example, to build confidence that the new
compound will reduce DILI concerns (and would not, to the contrary, introduce
an even higher liability). The objective of this project is to determine the
suitability of the Liver-Chip to predict DILI risk of a new candidate drug in the
same class as an earlier drug that was a clinical DILI positive. Suitability will be
demonstrated through (inter-lab) reproducibility and (intra-lab) repeatability of
the Liver-Chip as well as performance across a broader panel of human
hepatocyte donors.
27 Drydock Avenue, 5th Floor
Boston, MA 02210

Public health relevance
RFA-FD-24-030 Application Identifier: 1690535 Project Narrative: Emulate has submitted a Letter of Intent (LOI; DDT-IST-000016-LOI-2) that describes the above-mentioned context of use (pairwise DILI risk comparisons) and argues that the Liver-Chip is suitable as a drug development tool (DDT) for this use-case. The submission uses data derived from Ewart et al., 2022, to illustrate that the Liver-Chip provides sufficient accuracy to facilitate pairwise DILI risk comparisons by examining 12 FDA-approved drugs with known clinical DILI profiles. However, the suitability of the Liver-Chip to the described context of use would also benefit from a demonstration of the (inter-lab) reproducibility and (intra-lab) repeatability of the DDT as well as testing across a broader panel of human hepatocyte donors. 27 Drydock Avenue, 5th Floor Boston, MA 02210